Investigating a novel mechanism underlying prefrontal cortex dysfunction in autism and intellectual disability

“Investigating a novel mechanism underlying prefrontal cortex dysfunction in autism and intellectual
disability”
Project Summary / Abstract
Autism spectrum disorder and intellectual disability are two prevalent neurodevelopmental disorders which are
frequently diagnosed concurrently (ASD/ID). Difficulty with higher-level cognitive processing, including attention,
memory, and social interaction, is the hallmark of ASD/ID. Cognitive impairment is thought to be due to synaptic
dysfunction in the prefrontal cortex (PFC), though the mechanisms behind PFC synaptic impairment are largely
unknown. Converging evidence from several large-scale genetic analyses has identified ADNP, encoding a
neuronal chromatin remodeler, as a top risk gene for ASD/ID. Preliminary data shows that ADNP is reduced in
the PFC of patients with autism. This project employs viral-based gene transfer to knock down (KD) Adnp in
mouse PFC neurons to investigate the molecular underpinnings of ADNP deficiency. Initial investigation into the
effects of ADNP KD demonstrated cognitive behavioral impairment and glutamatergic synaptic deficits.
Transcriptomic analysis revealed upregulation of gene transcripts related to microglia-mediated inflammation,
which mirrors findings of microglial upregulation in human ASD/ID. Microglia are essential for fine-tuned synaptic
development in the PFC, but excess activation can damage surrounding neurons. Based on these findings, this
proposal intends to investigate a novel mechanism behind the PFC dysfunction in ASD/ID. The working
hypothesis is that the increase in pro-inflammatory transcription is due to loss of ADNP-mediated gene
repression in neurons. Consequently, increased microglial activation causes excess synaptic loss, leading to the
observed synaptic impairment. To test this, the transcriptional control of ADNP on microglia-mediating factors
will be investigated in Adnp KD (Aim 1). Microglial ablation will be employed in ADNP KD to evaluate the
influence of microglia on PFC synaptic function (Aim 2). Results gained from this study will provide insights into
novel therapeutic strategies for the PFC-based cognitive symptomatology of ASD/ID. This work will be done at
the State University of New York at Buffalo in the laboratory of my Sponsor Zhen Yan, PhD, a SUNY
Distinguished Professor with expertise in ASD/ID and epigenetic modulation. To supplement my transition into
an independent scientist, the training plan for this fellowship focuses on mastering new experimental techniques,
scientific communication, experimental design and rigor, and teaching and leadership. As a future physician-
scientist, I have additionally formulated an adjacent training plan with my clinical mentor, which is designed to
introduce me to clinical child psychiatry and help me to integrate clinical and research experience at this stage
of my career.

Public health relevance
Project Narrative Autism spectrum disorder (ASD) and intellectual disability (ID) are prevalent neurodevelopmental disorders (NDD). This research will reveal the biological function of a top-ranking high-confidence ASD/ID genetic risk factor, ADNP, in prefrontal cortical neurons.